Sestrins-mediated integration of leucine and exercise benefits for mitochondrial homeostasis

SUMMARY:
Preservation of mobility is one of the most significant health concerns of the elderly population. Exercise is the
best-established intervention that can preserve muscle mass and strength at later ages. Understanding how
exercise produces metabolic benefits in muscle is very important. In addition to exercise, diet is another key
determinant of muscle health. Among various dietary elements, leucine has been considered particularly
important because it is actively metabolized in muscle and can function against muscle degeneration. Previously,
leucine was thought to maintain muscle mass by activating mTORC1, a protein kinase upregulating general
protein and lipid anabolism. However, as demonstrated by our recent work and the work of others, mTORC1
upregulation rather produced degenerative phenotypes and wasting of muscle mass, while modest mTORC1
suppression was found to be beneficial for maintaining muscle homeostasis during aging. Therefore, leucine’s
role in the preservation of muscle structure and function may be independent of mTORC1 activation and needs
to be clarified. Over the previous funding period, our research group has been focusing on Sestrins, a family of
highly conserved proteins that are induced upon various stress inputs. Using both biochemical and genetic
methodologies, we have shown that Sestrins are multifunctional proteins that control many metabolism-
controlling pathways including redox signaling, protein kinase signaling (AMPK, mTORC1, mTORC2 and AKT),
and autophagy. Through genetic studies in mice and flies, we have shown that Sestrins have a critical
physiological role in mediating exercise benefits. Furthermore, experiments of others have shown that Sestrins
can bind and sense leucine. Although it is quite evident that Sestrins are at the crossroads between exercise,
leucine, and muscle homeostasis, mechanisms of how these components are connected to each other are
unclear. For instance, Sestrins, which inhibit mTORC1 (muscle anabolic kinase), function to preserve muscle
function and mass during aging and disuse. Leucine was suggested to antagonize Sestrin’s mTORC1-
suppressing activities, activating mTORC1. Yet, both leucine and Sestrins are beneficial for muscle health
despite playing opposite roles in mTORC1 signaling. We propose to solve the intricate relationships between
exercise, leucine and Sestrins through innovative methodologies combining purified protein complexes, ex vivo
culture of myotubes, in vivo animal models, and Seq-Scope, the state-of-the-art ultra-high-resolution spatial
transcriptomic technology developed by our own team. With respect to the expected outcomes, the work
proposed here could clarify the critical functions of Sestrins in integrating the metabolic benefits of leucine and
exercise in muscle homeostasis. Such results would have an important positive impact, because they will provide
us with a clearer picture of how leucine and exercise can improve muscle homeostasis and provide better
preventive and therapeutic rationales for preserving muscle strength and functionality during aging and disuse
by controlling Sestrin activities.

Public health relevance
PROJECT NARRATIVE Preservation of mobility is one of the biggest health concerns of elderly population associated with aging. Identification of cost-effective therapies that can preserve independence and healthy mobile capacity in the elderly would have a cumulative effect, influencing many other aspects of mental and physical health in a wide population demographic. Here we propose to investigate whether the proteins named Sestrins, which are natural inhibitors of diverse age-associated diseases, can be used as a new molecular target to preserve mobile capacity and quality of life in later ages.